Re-engagement at Discharge (Re-Charge): Improving post-hospital outcomes for HIV-infected adults in Zambia

PROJECT SUMMARY
In sub-Saharan African countries, HIV-infected patients suffer high rates of loss-to-follow-up and mortality
following hospital admission. Among HIV-infected patients at University Teaching Hospital (UTH) in Lusaka,
Zambia, we found 21% mortality three months after hospital discharge. Novel approaches are needed to re-
engage hospitalized patients in ART via the `side door' of the HIV care continuum. The Re-engagement at
Discharge (Re-Charge) study aims to understand and characterize the challenges of re-engagement in HIV
care following hospital discharge; to adapt an established intervention called Community HIV Epidemic Control
(CHEC) to support patients after discharge; and to test the discharge `d-CHEC' intervention to gain preliminary
data and experience for a future trial. CHEC is an evidence-based and PEPFAR-supported intervention that
utilizes community health workers (CHWs) to improve the HIV care continuum by addressing patient- and
system-level barriers, which we will adapt using the PRISM framework to improve post-hospitalization outcomes.
This clinical trial planning grant includes 3 Aims: in Aim 1, we will use qualitative methods to better
understand barriers to HIV care that arise after hospital discharge in Zambia. We will conduct in-depth
interviews and focus group discussions with patients, their caregivers, CHWs, clinicians, and other Zambian
health system stakeholders to understand the patient- and system-level obstacles to health care re-engagement
following hospital discharge and identify modifiable barriers to care that may be addressed by adaptations to
CHEC. In Aim 2, we will translate the findings from Aim 1 to adapt the CHEC model to improve patient
retention in care and viral suppression in the post-discharge period. In addition to program components
identified in Aim 1, we anticipate the adapted intervention may require: (a) early engagement with the CHEC
team before discharge; (b) an electronic discharge summary to facilitate flow of patient information from hospital
to the outpatient clinic; and (c) an early post-discharge home visit from a CHW. In Aim 3, the adapted d-CHEC
will be pilot-tested and evaluated in a pre/post trial. We will enroll a representative group of HIV-infected
adult inpatients at UTH before and after d-CHEC implementation, who will then be followed 6 months after
discharge. Outcomes to be assessed include retention in care at 6 months, viral suppression, and mortality.
Using mixed methods, we will evaluate the feasibility and acceptability of the adapted d-CHEC intervention from
multiple perspectives including patients, caregivers and health care workers.
The results will inform a fully-powered cluster-randomized R01 trial to evaluate effectiveness and costs of
the d-CHEC model. The project is significant as hospitalization is common among HIV-infected individuals, and
innovative as effective discharge interventions are lacking in sub-Saharan Africa. We are well prepared to
implement this R34 due to our strong understanding of the Zambian HIV health system and track record in large-
scale HIV programs, with expertise in clinical, qualitative, implementation science, and health systems research.

Public health relevance
PROJECT NARRATIVE In sub-Saharan African, hospitalization remains common among persons living with HIV (PLHIV), and after discharge their rates of loss to follow-up and mortality are unacceptably high. In a clinical trials planning grant, we will use qualitative methods to inform adaptation of an existing community health worker intervention (CHEC model) to improve post-discharge HIV care and follow-up among PLHIV with previously poor engagement in HIV care. The feasibility of the adapted intervention as well as its possible impact on post-discharge retention in care and other HIV outcomes will be evaluated using mixed methods.